Core C Admin Core

CORE C: ADMINISTRATIVE (Core Leader: Chris Sasse9)
Abstract:
The success of the Systems Genetics of Tuberculosis (SGTB) Program requires a robust
scientific and programmatic infrastructure to ensure smooth coordination and implementation
across program components and activities. As the hub of this program, the Administrative Core
will continue to provide both scientific and administrative oversight to facilitate effective
communication among projects and cores and to ensure that resources are used efficiently to
achieve our common scientific goals. The Administrative Core will be directed by Program
PD/PI Dr. Sassetti, who will be supported by an external Scientific Advisory Board. The
Administrative Core will ensure fiscal oversight and regulatory compliance, facilitate
communication, manage strategic planning, and oversee data and resources management and
sharing.